Direct and Indirect Neurogenesis in the Mammalian Neocortex

ABSTRACT
The neocortex is the most complex cellular system in the natural world, the seat of motor, sensory and
executive function. While many of the mechanisms responsible for neocortical formation have been
discovered, key aspects of how neural precursor cells produce the exceptional variety of cortical neurons are
unknown. Recent advances in genomic analysis and in vivo cellular labeling enable study of cortical
development at an unprecedented level of resolution. Here we propose to operationalize our ability to label and
track specific lineages of neurons, based on whether they were produced directly or indirectly from the apical
radial glia stem cells, to determine how lineage information is used to construct the proper circuits in the
developing neocortex. These studies will use emerging evidence and new tools to elucidate how neural
precursor lineages influence neocortical growth.

Public health relevance
NARRATIVE This project will use advanced genomic, molecular and in vivo studies to compare neural precursor cells throughout the neurogenetic period of the mouse and how the neurons they produce contribute to the mature cortical circuitry.